Leadership Administrative Core

The SA OAIC catalyzes scientific discoveries, promotes education and mentorship, and partners with other
scientists and the community at large to develop novel interventions to improve the health, quality of life, and
independence of older Americans. The LAC monitors, stimulates, sustains, evaluates, and reports progress
toward the SA OAIC's goal through the following Specific Aims:
1) Provide logistical support and promote operational cohesiveness to our OAIC; 2) Promote research
protocol adherence and maintain regulatory compliance with university and governmental policies for the
responsible conduct of OAIC-supported research; 3) Disseminate the scientific innovation accomplished by
OAIC investigators, inside and outside our institution, regarding the latest knowledge on geroscience and
promotion of healthy life extension; 4) Stimulate and facilitate interdisciplinary collaboration among OAIC
investigators, cores, committees, and projects, to advance basic science in aging biology from the bench to the
clinic; 5) Select and monitor pilot and exploratory studies and progress of Scholars aligned with the OAIC theme;
6) Monitor and evaluate OAIC progress, foster institutional collaborations, and leverage resources; 7) Provide
programmatic and scientific guidance to training programs, pilot studies, and resource cores (RCs); and 8)
Participate actively in the national OAIC network to help advance its mission of promoting independence in older
Americans.
The LAC coordinates annual reviews by an External Advisory Committee, an Institutional Advisory
Committee, and a Research Education Component (REC) Advisory Committee. With RC2, the LAC supports a
Community Advisory Committee (CAB). The LAC sponsors a weekly seminar on Geroscience, a monthly OAIC
Executive Committee Meeting, an Annual Conference on Aging (a 3-day activity), two one-day symposia on
aging per year, and bi-annual retreats where OAIC Scholars and pilot funding recipients present and discuss
their work with UTHSCSA leadership and local experts. These activities enable a rich scientific and academic
environment that further catalyzes transformative discoveries in translational geroscience.
The LAC implements an online research service tracking and management system developed by RC3
(PROS) for effective monitoring and evaluation of activities and key performance indicators, and efficient
preparation of reports. The LAC also provides an electronic management and communications platform that
enhances cohesion within the SA OAIC. The LAC promotes application of advanced managerial concepts (e.g.
Lean Six-Sigma) to streamline OAIC operations and foster coordination within RCs.
Collectively, LAC initiatives and activities have been extremely successful in optimizing performance of the
services that support science and advance the overall goals of our OAIC.